The immunobiological mechanisms of depression in perimenopause

PROJECT SUMMARY/ABSTRACT
This project aims to identify immunobiological mechanisms underlying the development of depression during the
perimenopause, in response to the NIMH funding opportunity “Mood and Psychosis Symptoms during the
Menopause Transition”. During the perimenopause, the risk for recurrence of depression is increased 13-fold
among women who previously had depression. Moreover, perimenopause overlaps with the age span exhibiting
the highest suicide rate for women. The perimenopause can last for several years and starts when estrogen and
progesterone levels begin to fluctuate, gradually declining. Sex hormones are powerful modulators of the
immune response and we therefore propose that changes in lymphocytes play a central role in depression during
this time. Notably, our previous work has demonstrated deficient regulatory T-cell responses in women with post-
partum depression and identified a specific pro-inflammatory profile (composed of cytokines and tryptophan
metabolites) that predicts depression during pregnancy. Importantly, our new pilot data derived from women with
severe depression in the perimenopausal age span reveals alterations in tryptophan metabolites that control T-
cell responses as well as in the methylation of genes involved in T-cell fate and chromatin remodeling. Taken
together, these data support our hypothesis that the perimenopausal hormonal shifts induce a pro-inflammatory
state, regulated by chromatin modifications in T-cells, that triggers depression in vulnerable women.
To test this hypothesis, we will enroll 150 perimenopausal women in a multi-site study to: 1) determine plasma
tryptophan metabolite and cytokine patterns in perimenopausal depression; 2) define epigenetic mechanisms in
lymphocytes that confer vulnerability to developing depression in perimenopause; and 3) identify inflammatory
and metabolic markers that normalize in a subset of 60 women recovering from depression (re-assessed 8
weeks after their initial visit), either treated with hormonal substitution therapy or untreated. We will undertake
careful clinical diagnostics and confirm perimenopausal status using established criteria. In all participants, we
will quantify plasma tryptophan metabolites, cytokines, and sex hormones. We will also define peripheral immune
cell populations and determine changes in DNA-methylation, chromatin accessibility and gene expression in
naïve T-cells. Finally, we will test the functional response to inflammatory stimulation in cultured lymphocytes
derived from the same women. We expect that women with perimenopausal depression will exhibit reduced
levels of immunoregulatory tryptophan metabolites and signs of peripheral inflammation as well as differences
in transcriptional regulation in lymphocytes. We predict that these distinct inflammatory responses will be linked
to the development of depression. We also expect improvement of depressive symptoms and reversal of
immunobiological markers in women receiving hormonal therapy. We envision that our project will lead to an
improved understanding of the molecular underpinnings of depression during perimenopause, aiding the future
identification of biomarkers of women at risk as well as the development of more effective treatments.

Public health relevance
PROJECT NARRATIVE This project aims to identify immunobiological mechanisms underlying the development of depressive symptoms in perimenopause (in response to PAR-23-097, issued by NIMH). Identification of such mechanisms is expected to aid the development of novel therapies and tools for identifying women at risk, which will lessen the impact of perimenopausal depression. The proposed research is therefore relevant to the missions of the NIMH and NIH.